Automated System for Detecting and Reporting Lapses in Performance of Activities of Daily Living for Independent and Cohabitating Persons with Alzheimer's Disease and Related Dementias

Project Abstract
In this SBIR Phase I project, ASTER Labs will significantly enhance an innovative system able to accurately
detect Activities of Daily Living (ADL) performed by persons with Alzheimer’s disease and related dementias
with new capabilities to determine specific compliance or non-compliance during their daily lives. This new
solution addresses a current unmet need to significantly streamline ongoing evaluations of persons’ abilities to
complete these important activities, and will equip care providers with reliable, automated, and on-demand
information to assist with assessing patients’ functional independence and making informed decisions on
interventions and level of care based on disease progression. In 2023, an estimated 6.7 million Americans live
with Alzheimer’s dementia. Nearly a third live alone and are more likely to suffer poorer health outcomes than
those cohabitating. Clinical research shows the importance of ongoing ADL assessment to establish diagnoses
of dementia and its progression. Current and proposed ways to automate this assessment (e.g. cameras,
beacon-based tracking systems) have been limited and criticized based on potential privacy concerns, reduced
accuracy and coverage, and need for significant infrastructure additions. Ubiquitous commercial products
primarily focus on fitness activities versus ADL, and further, inadequately address dementia patients’ unique
sensitivity to non-discreet, unfamiliar wearable devices. ASTER Labs’ work on two related systems leveraging
a discreet electronic shoe insole specifically designed for dementia patient care has identified a strong need to
complement clinical interventions (e.g. compensatory memory techniques, memory notebooks) to help prevent
or delay dementia onset and preserve functional independence. As those with cognitive impairment risk
inaccurate recollection of ADL performed throughout the day, ASTER Labs’ system is able to automatically and
accurately detect and identify ADL. However, an unmet need exists to enhance the ability of dementia care
providers to receive verifiable notifications of ADL compliance, based on whether automatically-detected
activities were performed as expected, and according to specific constraints on frequency of occurrence.
Therefore ASTER Labs’ proposed ActivVerify system will leverage its technology using intelligent processing of
WiFi, GPS, inertial, and audio sensor data from a small hardware suite concealed in a shoe insole and
unnoticeable to the wearer, combined with new data analysis software capabilities that use constraint
scheduling and matching to determine and verify ADL compliance. In Phase I, the prototype system will be
assembled, with feasibility demonstrated by functional evaluation in a focus group study with caregivers,
physicians, and cognitive rehabilitation therapists of patients with dementia. The system’s ADL compliance
accuracy will be determined in timed experiments by ASTER Labs’ engineers wearing the prototype insoles.
Phase I testing will provide the success criteria for the Phase II program, which will include a human study of
the fully-operational system in home and independent living settings to establish the efficacy of this approach.

Public health relevance
Project Narrative As the number of elderly individuals suffering from dementia in the U.S. continues to significantly increase, solutions are needed to assist these individuals in maintaining functional independence for as long as possible while still safe, and provide caregivers and clinicians ongoing assessment of Activities of Daily Living, in order to improve outcomes from continuous evaluation of patients’ disease progression over time. Leading clinical research on practical interventions shows strong benefits from patients’ use of compensatory memory techniques to report ADL and other healthy behaviors performed, and these interventions, along with appropriate responses and adjustments to caregiving, have helped prevent or delay dementia onset and preserve functional abilities. The proposed research addresses an important unmet need to continuously monitor, and accurately and automatically validate whether expected ADL were performed as expected, without the need for direct caregiver observation, which will provide remotely-located caregivers, physicians, and cognitive rehabilitation therapists with verified and reliable information on whether these important activities were achieved or had lapsed, and promoting informed decisions on diagnosis, interventions, and level of care.